Molecular mechanisms that regulate the degradation of dying cells

Project Summary/Abstract
Molecular mechanisms that regulate the degradation of dying cells
During metazoan development and adulthood, many cells undergo cell suicide (apoptosis). In addition,
pathological stresses often induce the necrosis of cells. Phagocytosis is a “cell-eating-cell” event in which dying
and senescent cells, damaged axons and synapses, and invading pathogens are internalized by phagocytes
and degraded inside phagosomes. Swift clearance of dying cells in mammals is critical for tissue remodeling,
the resolution of the wound area, and the suppression of harmful inflammatory and autoimmune responses.
Cancer research and treatment are also related to the clearance of dying cells. We have been studying the
phagocytosis of cells that undergo apoptosis, a genetically controlled process of cell suicide in the nematode
C. elegans. We have discovered many proteins that facilitate the recognition, engulfment, and degradation of
dying cells. We have delineated several signaling pathways that drive each step of the dying cell-clearance
process. These include a pathway that initiates the maturation of phagosomes by promoting the fusion of
lysosomes to phagosomes. This pathway is driven by CED-1, a phagocytic receptor, and its downstream
adaptors and effectors. We believe what we learn from C. elegans can be translated to humans and impact
human health. Recently, we made two discoveries. (I) We found that the double-membrane autophagosomes,
which are known to help clear intracellular protein aggregates and damaged organelles through autophagy,
actively fuse to the single-membrane phagosomes and facilitate the degradation of the engulfed apoptotic
cells. We coin the term autophagosome-phagosome fusion (AP-fusion). Our findings reveal a novel crosstalk
between autophagy and phagosome processing. (II) We found that the precise temporal regulation of CED-1
on the surfaces of nascent phagosomes, which involves mechanisms that remove CED-1 from the
phagosomal membrane, is necessary for the initiation of maturation. Here we propose to deepen and broaden
our research premise by following these two discoveries. Investigate the novel mechanisms that regulate the
AP-fusion (Project 1), the phagosome-induced autophagosome biogenesis (Project 2), and the temporal
activation and inactivation of CED-1 on nascent phagosomes (Project 3). The outcome of the proposed
projects will shed light on our understanding of how intracellular organelles participate in cell-cell interaction
and further contribute to treating human diseases related to defects in phagocytosis and autophagy.

Public health relevance
Project Narrative This proposal highlights our planned approaches to investigate how dying cells in animal bodies are clearer efficiently through phagocytosis and degradation, using the nematode C. elegans as our model organism. The clearance of dying cells protects humans from the harmful inflammatory and auto-immune responses induced by the contents of the dying cells. Understanding the mechanisms controlling this process will have important therapeutic implications, in fighting chronic inflammatory and autoimmune diseases, and in developing new strategies to target cancer cells for engulfment and digestion.